Targeting the Metabolic Regulator SIRT5 in Acute Myeloid Leukemia

PROJECT SUMMARY
TARGETING THE METABOLIC REGULATOR SIRT5 IN ACUTE MYELOID LEUKEMIA. AML is an aggressive
hematologic malignancy with <30% long-term survival. The current therapy standard, chemotherapy alone or
combined with allogeneic stem cell transplant, has not changed for decades. Despite initial responses, most
patients eventually relapse, suggesting persistence of leukemia initiating cells in protective niches. Inhibitors of
FLT3 or mutant isocitrate dehydrogenase 1/2 (IDH1/2) have expanded therapy options and validated the
paradigm of genotype-directed therapy. However, even with these new drugs, relapse is common and frequently
due to selection of subclones with resistance mutations in the drug target. Unlike FLT3 and IDH1/2 inhibitors,
the BCL2 inhibitor venetoclax is active in multiple AML genotypes, indicating that targeting shared vulnerabilities
in a genotype-agnostic manner can be effective. Unfortunately many venetoclax-induced responses are not
durable as leukemia cells adapt by activating alternative anti-apoptosis mechanisms or by reprogramming
mitochondrial metabolism. Microenvironmental protection, intra-tumoral heterogeneity and metabolic flexibility
limit the utility of current AML therapies. To identify new therapy targets in AML, we adapted an shRNA screen
for testing primary AML cells under bone marrow microenvironment-like conditions. We discovered that many
AML patient samples are highly dependent on SIRT5, while normal CD34+ cells are not. SIRT5 is a lysine
deacylase implicated in the regulation of energy metabolic pathways, including oxidative phosphorylation
(OXPHOS), fatty acid β-oxidation and glycolysis. SIRT5 knockdown (KD) reduces growth and increases
apoptosis in most AML cell lines, with consistent results upon disruption of SIRT5 using CRISPR/Cas9 or
NRD167, a novel cell-permeable SIRT5 inhibitor. Genetic absence of Sirt5 impairs in vitro transformation of
mouse hematopoietic cells by several myeloid oncogenes, including MLL-AF9, and attenuates leukemogenesis
in vivo. At a biochemical level, SIRT5 KD or inhibition with NRD167 is associated with reduced OXPHOS,
reduced glutathione levels and increased mitochondrial superoxide, suggesting that AML cells depend on SIRT5
to maintain redox homeostasis. Sirt5-/- mice are viable with minor metabolic abnormalities, suggesting that in
vivo inhibition of SIRT5 would be tolerated. We hypothesize that SIRT5 is a therapy target in AML and will test
this in three Specific Aims: (1) Identify and validate SIRT5-regulated metabolic pathways in normal and
AML stem and progenitor cells. (2) Identify biomarkers of sensitivity to SIRT5 inhibition in primary AML
cells. (3) Identify a potent, selective, and bioavailable SIRT5 inhibitor, starting from the NRD167 tool
compound. Our work will rigorously test whether SIRT5 is a therapy target in AML, clarify the mechanisms
underlying SIRT5 dependence, and identify potent and selective SIRT5 inhibitors for future clinical development.

Public health relevance
PROJECT NARRATIVE Acute myeloid leukemia is an aggressive blood cancer that is typically incurable and fatal with current treatments. We have discovered that the survival of AML cells, unlike healthy white blood cells, depends on an enzyme called Sirtuin 5, for which there are no drug or targeted treatment options. We will thoroughly characterize the biology of Sirtuin 5 and simultaneously work to develop a drug to treat patients with acute myeloid leukemia.